Single Session Intervention and Interpersonal Therapy for Adolescent Depression in Mozambican Primary Care Clinics: A Hybrid Effectiveness/Implementation Cluster Randomized Trial

PROJECT SUMMARY
Depression is the leading cause of disability in adolescents worldwide. While multiple adolescent depression
interventions have been demonstrated effective in low- and middle-income countries (LMIC), where 90% of the
world’s adolescents reside, research on their real-world implementation is lacking. Since 2019, we have
collaborated with the Mozambican Ministry of Health to pilot implementation of routine depression screening and
Group Interpersonal Therapy for Adolescents (IPT-AG) within primary care clinics of the national health system
(K01MH120258). Our results indicate that routine screening leads to a 50-fold increase in identification of
depressed adolescents and that IPT-AG is effective at reducing symptoms. However, as similarly seen following
universal screening in high-income countries, treatment uptake was low, with around 90% of depressed
adolescents not entering IPT-AG due to lack of time and interest. Single session interventions (SSIs), structured
programs involving just one visit with a provider, have been proposed as a scalable solution to close the mental
health treatment gap. SSIs are not intended to replace traditional therapies, but instead were designed to address
the reality that most patients do not return for mental health care after their first contact. The digital SSI Project
Personality is among the best supported SSIs for depression, with several trials in U.S.-based adolescents
demonstrating its effectiveness at directly reducing depression symptoms and increasing engagement in further
mental health support. Therefore, it may fill a critical gap in Mozambique and other LMIC by promoting
engagement in traditional, longer-term treatment among depressed adolescents as well as reducing symptoms
in those who remain uninterested or unable to engage in further care. Yet, the effectiveness of SSIs has only
been tested in two LMIC, and no research has evaluated SSI implementation in a LMIC context. Here, we
propose a Hybrid Type I Effectiveness-Implementation cluster randomized control trial to evaluate offering
Project Personality immediately after depression screening along with referral to IPT-AG (SSI+IPT-AG)
compared to referral to IPT-AG alone for depressed adolescents in Mozambican primary care clinics. We will
test our hypothesis that there will be greater reductions in depression symptoms in the SSI+IPT-AG than the
IPT-AG alone arm. We will also evaluate the clinical impact of SSI alone and the effectiveness of IPT-AG alone,
as well as examine hypothesized intervention mechanisms (Aim 1). Moreover, we will use trial cost and outcomes
data to project the cost-effectiveness and budgetary impact of scaling-up the interventions across Mozambican
primary care (Aim 2). Finally, we will evaluate implementation outcomes and determinants to explore factors
influencing intervention adoption, penetration, fidelity, and sustainability (Aim 3). Together, this study will define
clinical outcomes, cost-effectiveness, and implementation determinants of two evidence-based interventions for
adolescent depression. These interventions have the potential to provide an innovative approach to sustainably
deliver depression care within Mozambique and other LMIC to close the global treatment gap.

Public health relevance
PROJECT NARRATIVE Globally, depression is the leading cause of disability in adolescents, and more than 90% of all adolescents live in low- and middle-income countries (LMIC), where mental health services are extremely limited. The proposed study will investigate the effectiveness and implementation of routine screening and treatment for adolescent depression integrated within primary care clinics of Mozambique, an LMIC in southern Africa. Results of this project can inform policy and mental health service delivery in Mozambique and may serve as a model for other LMIC to reduce the global burden of adolescent depression.